A scalable cruciferous vegetable intervention to reduce bladder cancer recurrence and progression

Bladder cancer is one of the top 10 cancers in the nation, and the 4th most common cancer in men. The majority
(70-80%) of bladder cancer is diagnosed at early stages, known as non-muscle invasive bladder cancer
(NMIBC). NMIBC can be removed, yet typically recurs (up to 75%), and some progress with poor prognosis. The
majority of patients have no treatment available besides life-long active surveillance, rendering bladder cancer
the most expensive cancer to treat. Compelling preclinical and epidemiological evidence show that dietary
isothiocyanates (ITCs) from cruciferous vegetables (cruciferae) are particularly potent against bladder cancer
given their exclusive excretion to the urine and exposure to the bladder epithelium. Our prospective cohort study
also found that high intake of cruciferae, i.e., high ITCs, was associated with delayed bladder cancer recurrence
and reduced progression. We translated our bench-side findings to develop a novel, dietary intervention to
reduce bladder cancer recurrence and progression in NMIBC patients. Our intervention—POW-R-Health—
significantly increased cruciferae intake and urinary ITC levels from baseline to 6 months, achieving urinary ITC
levels sufficient to stop or kill at least 50% of bladder cancer cells in in vitro models. However, a considerable
literature has documented the diminished effects of behavioral dietary interventions over time. To ensure POW-
R Health’s impact on NMIBC outcomes, urinary ITC levels need to be sustained past 6 months because the
majority of NMIBC recurrences occur within 24 months post-diagnosis. To sustain urinary ITC levels, we propose
to establish the efficacy of POW-R Health with a maintenance component to maintain urinary ITC levels to at
least 10 M through a 2-arm randomized controlled trial (RCT). We hypothesize that the POW-R Health +
Maintenance arm will result in higher urinary ITC levels maintained compared to the POW-R Health Only arm.
Aim 1: Use a systematic process to adapt maintenance strategies from evidence-based dietary interventions to
develop an 18-month cruciferae-focused maintenance component for NMIBC survivors. We will expand POW-
R Health by adding the adapted maintenance component. Aim 2: Assess the efficacy of POW-R Health +
Maintenance compared to POW-R Health Only using a 2-group RCT design in 344 participants with the primary
outcome of urinary ITC and the secondary outcome of cruciferae intake. Assessments will occur at baseline, 6,
12, 18, and 24 months. Exploratory Aim 3: Assess the preliminary efficacies of POW-R Health + Maintenance
versus POW-R Healthy Only on bladder cancer recurrence and progression at 24 months through medical chart
review. Recurrence and progression will be assessed as time to the event at 24 months post enrollment. Urinary
proteomics will be conducted on urine samples to provide biological insights on ITC’s effects in the bladder. Our
overall goal is to develop a new delivery of care model whereby our intervention can be implemented in
healthcare institutions to reduce bladder cancer recurrence and progression for population-level impact on
survivorship.

Public health relevance
Project Narrative Research has shown the potential beneficial effect of eating more cruciferous vegetables (e.g. arugula, cauliflower) on improving bladder cancer outcomes, since bladder cancer survivors have a high risk of the cancer coming back, i.e., bladder cancer recurrence. We created a dietary intervention that helped bladder cancer survivors eat more cruciferous vegetables; now we want to expand our intervention to focus on preventing and/or delaying the recurrence of bladder cancer. If proven successful, this intervention would improve the lives of bladder cancer survivors.